Project 3: Identifying Molecular Vulnerabilities to Improve Interferon Gene Therapy in Bladder Cancer

ABSTRACT
Nadofaragene firadenovec (nadofaragene) is a combination of an adenovirus encoding human interferon-alpha
(IFNα) and a detergent excipient (Syn-3) that facilitates gene transfer into the bladder urothelium. It was
developed for the adjuvant intravesical treatment of patients with high-risk non-muscle invasive bladder cancer
(NMIBC) and recently received FDA approval for the subset who have BCG unresponsive disease. Our group
was responsible for developing nadofaragene from bench to bedside, taking it through proof-of-principle
preclinical studies through Phase I-III clinical trials. The drug’s dosing schedule (once every 3 months) is
advantageous as compared to other therapies, and its single-agent activity was superior to other approved and
investigational agents. In published preclinical studies we reported that IFNα directly causes cell death in some
bladder cancer cell lines via autocrine production of TRAIL (TNFSF10) and inhibits orthotopic tumor growth via
inhibition of angiogenesis, and it strongly upregulated T-cell and checkpoint proteins in syngeneic murine models
and urine collected from patients enrolled in the Phase-I clinical trial. Here we propose to define nadofaragene’s
molecular mechanisms much more deeply and comprehensively. Our hypothesis is that luminal-basal molecular
subtype lineage plasticity plays a major role, and we will exploit novel preclinical models and human specimens
to test this hypothesis. In Specific Aim 1 we will use a panel of human organoid models to validate the
observation we have made in conventional cell lines that luminal cancers are more sensitive to nadofaragene
direct cytotoxicity, and we will perform mechanistic studies to define the molecular mechanisms involved. In
Specific Aim 2 we will compare the effects of adenoviral IFN on the tumor immune landscapes in spontaneous
murine models of luminal and basal cancer that were developed by our collaborators in Project 2, and in Aim 3
we will perform longitudinal urine samples and whole organ analyses of the effects of nadofaragene in patients,
exploiting the unique expertise of Project 1’s investigative team. The results of this work will help us to identify
biomarkers that predict response or resistance and novel candidate drugs to combine with nadofaragene to
expand its therapeutic activity.

Public health relevance
PROJECT NARRATIVE Nadofaragene firadenovec is a new drug for bladder cancer that was recently approved by the FDA. Our goal in this project is to identify the mechanisms that it elicits to control cancer growth so that we can develop strategies to distinguish patients who will benefit from the drug from those who will not. We also anticipate that this information will help us identify other drugs that can be combined with nadofaragene to enable even more patients to benefit from its effects. Our project will rely heavily on tools and experimental models developed by us and the two others described in this Program Project application.